Cardiomyocyte Non-autonomous Factors and Cardiac Regeneration in Large Mammals

Project Summary
In contrast to the cardiomyocytes (CMs) from lower vertebrates, adult mammalian CMs possess very limited
regenerative potential as a result of cell cycle exit. Interestingly, neonatal mice retain cardiac regenerative
capacity, which is lost by postnatal day 7. We have recently shown that 1-day-old pigs can also regenerate lost
myocardium in response to myocardial infarction (MI). This regeneration is mediated by the proliferation of
preexisting CMs, which does not occur when CMs permanently exit the cell cycle. Mechanisms underlying the
injury-mounted regenerative response especially in large mammals are not fully understood. However,
investigating underlying mechanisms is likely to identify novel targets for future therapeutic interventions.
Recent studies in fish and rodents emphasized the critical importance of vascularization and autonomic
innervation of the regenerating myocardium in zebrafish and neonatal mouse hearts. Besides their function to
provide nutrients, transport metabolites and enable adaptation to stress, it is unknown whether vascular and
neuronal cells, via paracrine interactions, also promote CM proliferation. Intriguingly, our preliminary data
support the idea that soluble factors, e.g., cytokines, secreted from vascular endothelial cells and peripheral
sympathetic neurons significantly stimulate cell cycle activity of co-cultured human induced pluripotent stem
cells-derived CMs, suggesting a critical role of nonmyocyte-CM interactions in modulating CM proliferation in
hearts of larger mammals post injury. In this project, we will exploit the established high regenerative capacity
of the neonatal pig heart model to experimentally address the role of nonmyocytes in injury-induced cardiac
regeneration in large mammals. Two specific aims are proposed. Aim 1 is to define the role of early
revascularization in injury-mounted cardiac regeneration. We will test the hypothesis that early
revascularization is essential for cardiac regeneration in neonatal pigs, and determine whether angiogenesis
promotes cardiac regeneration through the release of pro-myogenic factors from endothelial and/or smooth
muscle cells and/or via de novo formation of functional vessels for maintenance of CM viability. Aim 2 is to
delineate the role of autonomic innervation in injury-mounted cardiac regeneration. We will test the
hypothesis that innervation is essential for post injury cardiac regeneration in neonatal pigs, and determine if
biomaterial-mediated epicardial delivery of angiogenic and neurotrophic factors enhances cardiac regeneration
in neonatal pigs post MI.

Public health relevance
Project narrative Myocardial infarction occurs in many types of congenital heart diseases and surgical treatments. Recent case reports indicate that newborn patients may be able to regenerate myocardium and recover from severe myocardial infarction that occurred shortly after birth. In this project, we will exploit the high regenerative capacity of neonatal pig heart model to decipher the mechanisms of heart regeneration in large mammals.